Respiratory Health Effects of Global Climate Change Workshop

DESCRIPTION (provided by applicant): Global climate change is expected to have impacts on human health, with likely adverse impacts on respiratory health. Anticipated respiratory impacts include heat-induced increases in air pollution, increased allergic pollen exposures from changes in climate, increased vector-born respiratory disease, and heat-stress related critical care illness. Further research is needed to better understand the probability of these projected respiratory health effects, understand their links with climate change, and develop population and individual mitigation strategies to protect human health. The proposed workshop will convene respiratory disease experts and climate change experts to develop a document for publication that describes important research questions related to the respiratory health effects of global climate change, including research questions for the developed, developing and underdeveloped world, appropriate mechanisms for answering research questions, and knowledge gaps and research infrastructure needs to address important research questions. PUBLIC HEALTH RELEVANCE (modified from application): As most recently described in the Intergovernmental Panel on Climate Change 2007 Fourth Assessment Report, global climate changes are likely driven by human activities and, unless quickly abated, will likely have severe and prolonged impacts on climate, including higher average temperatures and disruptions in existing weather and precipitation patterns that will adversely impact public health. Research is needed to better quantify, understand and develop mitigation and adaptation strategies to the anticipated direct and indirect respiratory health effects of climate change. Research is needed to address relevant questions for the developed, developing and under-developed world.

Public health relevance
Project Narrative As most recently described in the Intergovernmental Panel on Climate Change report 2007 Fourth Assessment Report - global climate changes are likely driven by human activities and, unless quickly abated, will likely have severe and prolonged impacts on climate, including higher average temperatures and disruptions in existing weather and precipitation patterns that will adversely impact public health. Many of the anticipated public health impacts of global climate change will have direct or indirect impacts on respiratory health including: 1. Increased burden of allergy related-disease from higher pollen counts 2. Temperature-related increases in exposure to ozone pollution 3. Temperature-related increases in exposure to particulate matter 4. Respiratory failure related with heat waves 5. Drought-related changes resulting in increased exposure to particulate matter Research is needed to better quantify, understand and develop mitigation and adaptation strategies to the anticipated direct and indirect respiratory health effects of climate change. Research is needed to address relevant questions for the developed, developing and under developed world. The workshop participants will be asked to develop key research questions, described needed resources and research infrastructure to address the respiratory health effects of global climate change. To address our knowledge gaps on the respiratory health effects of climate change, the ATS proposes to convene a workshop of experts develop a document that describes important research questions related to the respiratory health effects of global climate change, including research questions for the developed, developing and underdeveloped world, appropriate mechanisms for answering research questions, knowledge gaps and research infrastructure needs to address important research questions. The target audience of the workshop report will be U.S and international researchers and U.S. and international funders of human health and environmental research. The proposed workshop will be hosted by the American Thoracic Society (ATS). Established in 1905 as a group of physician dedicated to improving the research, treatment and prevention of tuberculosis, the ATS has grown into an international society with 15,000 members specializing in respiratory, critical care and sleep medicine. The ATS hosts the premium scientific meeting for pulmonary, critical care and sleep medicine and publishes three peer-reviewed scientific journals.